Quality Assurance and Quality Control Project Management: Improving Submissions and Study Conduct in the Human Subjects Research Prior Approval Process

PROJECT SUMMARY The NCATS Human Subjects Research (HSR) Prior Approval (PA) process for KL2 Scholar Projects and certain Pilot Projects has been challenging for CTSA institutions to navigate. The Indiana CTSI will create a dedicated Quality Assurance/Quality Control (QA/QC) Project Manager role to improve quality and facilitate the HSRPA process. The long-term goal is to improve the quality of human subjects research submissions, make the overall process more efficient, and provide quality assurance for the ongoing conduct of research at the Indiana CTSI, with a particular emphasis on young investigators. The objectives are to decrease the review timeline from the time of award to study startup by supporting the education of young investigators and to ensure research conducted is at the highest quality so that important clinical research discoveries can positively impact patient outcomes more quickly. The specific aims are to: (1) Create a dedicated QA/QC position within the Indiana CTSI to perform quality reviews of CTSA-related submissions to NCATS, submit to the HSS, and manage the overall process; (2) Support applications by interfacing with KL2 Scholars and Pilot Project awardees throughout the IRB submission process; (3) Monitor funded projects once approved to ensure data quality and compliance; and (4) Offer QA/QC support to other K-funded young investigators. Accomplishing the above aims will enable measurable improvements in all stages of the HSRPA process and study conduct for KL2 Scholar Projects and certain Pilot Projects. In particular, individualized support to young investigators throughout their project will greatly enhance their training and preparation for a productive career in clinical research.

Public health relevance
It is essential that the next generation of researchers have the ability to navigate complex policies and regulations. This project will provide hands-on guidance for federal and local policy and regulatory requirements to early-career researchers and other researchers who receive certain NIH funding. It will also support researchers by ensuring that their research is conducted according to the highest quality standards.